EFFECT OF HEPARINE ON ENDOTHELIN LEVELS IN PATIENTS WITH CHF

The hypothesis of intravenous administration of a continuous infusion of heparin will result in the suppression of endothelin concentrations in patients with heart failure and discontinuation of heparin results in a 'rebound' increase in et-1 concentrations will be tested.